Interactions between diet and cognition

Project Summary
Consumption of an obesity-promoting “Western diet” (WD) is strongly associated with cognitive
impairment and dementia risk, even independent of obesity 1-5. The hippocampus (HPC), a brain region
classically associated with memory function and more recently with energy balance, is particularly vulnerable
to the negative effects of WD consumption 4, 6. Emerging evidence from both humans and rodent models
identifies the juvenile and adolescent stages as especially vulnerable developmental periods for WD-induced
HPC dysfunction 5, 7-9. Our preliminary results presented herein reveal that juvenile and adolescent WD
consumption is associated with long-lasting memory impairments and hyperphagia during adulthood.
Remarkedly, these negative outcomes are present in the absence of obesity and persist despite a healthy diet
intervention beginning at adult onset. This proposal will discover the biological mechanisms mediating early
life WD-induced programming of disordered memory performance and eating behavior during adulthood.
We recently discovered a functional link between early life sugar consumption, the gut microbiome, and
HPC dysfunction 10. Applying an analogous approach with our novel early life WD model (sugar + saturated fat
+ processed foods), we have identified substantial gut microbiome changes in early life WD-fed vs. control rats,
including alterations in bacterial populations that are correlated with HPC-dependent memory performance.
The functional relevance of these results will be mechanistically evaluated in this proposal. Given that WD-
induced microbiome changes are associated with changes in brain acetylcholine (ACh) signaling 11, and that
HPC ACh signaling promotes memory function 12-18, additional experiments will explore our novel hypothesis
that aberrant HPC ACh signaling is a neural basis for WD-associated HPC dysfunction. This hypothesis is
supported by our preliminary results showing that early life WD yields long-lasting reductions in markers of
ACh tone, and that nonspecific cholinergic receptor agonism reverses early life WD-associated HPC-dependent
memory impairments. Proposed experiments utilize state-of-the-art in vivo imaging and pharmacological
approaches to identify mechanisms linking early life WD consumption, HPC dysfunction, and ACh signaling.
In addition to regulating memory function, the HPC has emerged as a key brain region in the higher-
order control of food intake 6, 19. Our preliminary results show that early life WD consumption yields increased
caloric intake driven by elevated meal size, an effect that persists even after a healthy diet intervention.
Additional preliminary data reveal that HPC ACh binding dynamically increases throughout the course of a
meal, and this effect is highly predictive of meal size. We will expand these results by evaluating how early life
WD influences dynamic HPC ACh binding during meal consumption and sensitivity to various physiological
satiation signals. Collective results from the proposal will identify novel neurobiological mechanisms through
which the early life dietary environment programs for impaired cognition and altered energetic outcomes.

Public health relevance
Project Narrative Unhealthy diets high in sugar and saturated fat (a “Western diet”) are commonly consumed by children and are associated with both obesity and cognitive impairments. The hippocampus is a brain region that regulates memory function and food intake control, and this region is particularly vulnerable to early life Western diet consumption. Here we investigate the biological and behavioral mechanisms through which early life consumption of a Western diet negatively affects memory function and feeding-related behaviors later in life.